L-THREO-DOPS IN TREATMENT OF PARKINSONISM &AUTONUMIC DYSTROPY

A clinical trial of the effectiveness of L-threo-3,4-dihydroxyphenylserine (L- threo-dops), a synthetic amino acid that is converted to norepinephrine by the enzyme L-aromatic amino acid decarboxylase, in the control of neurogenic orthostatic hypotension and "freezing" phenomena in patients with Parkinson's disease.